Exploratory-Project 2

PROJECT SUMMARY
Suicide is inherently an affectively charged topic and clinicians often experience anxiety and low self-efficacy in
detecting and intervening with those at risk. This anxiety leads to poor implementation of evidence-based suicide
screening, assessment, and interventions (SSAIs). Clinician anxiety and low self-efficacy related to SSAI use
are thus candidate targets for implementation strategy design to optimize SSAI uptake in diverse mental health
settings. This exploratory project brings together an interdisciplinary team to leverage decades of research on
behavior change from exposure theory to design and pilot-test an exposure-based implementation strategy
(EBIS) to target clinician-level anxiety about SSAI use. We will test the effect of EBIS as an implementation
strategy to augment Implementation as Usual (IAU) to enhance SSAI implementation in community mental health
settings. Specifically, Aim 1 will use participatory design methods to develop and refine EBIS in collaboration
with a stakeholder advisory board of clinicians, administrators, and content experts. In Aim 2, we will further
iteratively refine EBIS with up to 15 clinicians in a pilot field test, using rapid cycle prototyping, in collaboration
with the INSPIRE Methods Core. Clinicians in Aim 2 will also provide qualitative feedback on EBIS’ ability to
mitigate anxiety and increase self-efficacy to deliver SSAIs to optimize our ability to engage target mechanisms
of clinician anxiety. Aim 3 will test the refined EBIS in a pilot implementation trial in which 40 community mental
health clinicians will be randomized to receive either IAU or EBIS+IAU. Primary Aim 3 dependent variables are
EBIS acceptability and feasibility, measured through questionnaires, interviews, and recruitment and retention
statistics; this pilot trial is not intended to be powered to detect effects. Secondary outcomes are preliminary
effectiveness of EBIS on implementation outcomes (SSAI adoption and fidelity), and engagement of target
implementation mechanisms (clinician anxiety and self-efficacy related to SSAI use), assessed via mixed
methods (questionnaires, chart-stimulated recall, observer-coded role plays, and interviews). We have two
exploratory hypotheses, which we will evaluate via mixed methods: (1) EBIS will engage target implementation
mechanisms by lowering anxiety and increasing self-efficacy better than IAU; (2) Clinicians randomized to EBIS
will show improved SSAI adoption and fidelity. We also will gather data on other possible implementation
mechanisms using questionnaires and qualitative interviews to probe for contextual implementation barriers to
SSAI use not addressed by EBIS to inform augmentation prior to fully powered evaluation.
This project addresses a major gap in the implementation of suicide prevention evidence-based practices by
developing a novel implementation strategy to augment IAU that targets mutable implementation mechanisms
unique to SSAI use. Study goals are consistent with NIMH research priorities and aligned with the overall mission
of INSPIRE. Results will inform a fully powered R01 to test EBIS’ effect on implementation and patient outcomes.